20th Biennial International Conference on Lung and Airway Fibrosis (ICLAF)

PROJECT SUMMARY The Organizing Committee of the International Colloquium on Lung and Airway Fibrosis (ICLAF) is requesting support for its 2018 meeting to be held October 14-18, 2018, at the Asilomar Conference Grounds in Pacific Grove, California. The primary objective of this grant application is to enable junior scientists and scientists from groups traditionally underrepresented in science to participate in ICLAF 2018 through financial assistance and targeted outreach. ICLAF is a biennial scientific meeting dedicated to the science of lung fibrosis. Now in its 20th iteration, ICLAF 2018 will bring together scientists from clinical, translational and basic backgrounds to discuss original research, identify critical gaps in knowledge, and develop collaborative relationships and future research opportunities. Every effort will be made to attract a diverse group of attendees, with particular attention to junior investigators and investigators who are traditionally underrepresented in science. We believe events like ICLAF 2018 are essential to catalyzing scientific progress and discovery. Asilomar is a unique conference venue ? known as the Monterey Peninsula's “Refuge by the Sea”, it is a 107-acre state beach and conference center that provides conference attendees with a retreat-like atmosphere conducive to scientific discussion and innovation. Insuring appropriate representation of groups traditionally underrepresented in science is a central priority of ICLAF 2018 and the primary objective behind this grant application. The majority of the ICLAF 2018 Organizing Committee (4 of 7) and nearly half of the overall conference leadership (20 of 46) consists of women and members of groups traditionally underrepresented in science. ICLAF 2018 is also committed to involving junior scientists in the leadership and content of the conference, with two junior scientists included on the Organizing Committee. ICLAF 2018 will feature eight scientific sessions, with each session consisting of two 30-minute “invited lectures” and two 15-minute original research presentations. It will also feature original research posters, a junior investigator forum for presentation of research by trainees, and small group discussions identifying future priorities and challenges for our scientific community. ICLAF 2018 will aim to publish its proceedings in a major academic journal to allow the larger lung fibrosis community to review and comment on our presentations and discussions.

Public health relevance
PROJECT NARRATIVE ICLAF is a biennial scientific meeting dedicated to the science of lung fibrosis. ICLAF 2018 will be held at the Asilomar Conference Grounds, located in Pacific Grove, California. The four-day conference will bring together scientists from clinical, translational and basic backgrounds to discuss original research, identify critical gaps in knowledge, and develop collaborative relationships and future research opportunities. It will feature eight scientific sessions, with each session consisting of two 30-minute “invited lectures” and two 15-minute original research presentations. It will also feature original research posters, a junior investigator forum for presentation of research by trainees, and small group discussions identifying future priorities and challenges for our scientific community.